CORTICOTROPIN RELEASING FACTOR (HCRF)--POSSIBLE ROLE IN ADDICTIVE DISORDERS

We are studying the effects of two to four different doses of CRF on neuroendocrine responsivity and also on related immune responsivity, and thus possibly the related anti-inflammatory status, in normal volunteer subjects as well as in subjects with defined addictive diseases, either in drug free treatment or pharmacotherapy for their disorder.